STABLE GLYCOSIDASE LIBRARY FOR THERAPEUTIC SYNTHESIS

ThermoGen proposes to isolate a library of thermostable glycosidases for use in the synthesis of carbohydrate containing therapeutics. Phase I will identify thermostable glycosidases from ThermoGen's large library of thermophiles and Escherichia coli clone banks of themophilic organisms. Identified glycosidases will be characterized and categorized on the basis of their hydrolytic and synthetic substrate specificity. Phase II will involve the further characterization of these and additional thermostable glycosidases for commercial development. This library of thermostable glycosidases will be available to synthetic chemists for the development and synthesis of carbohydrate containing pharmaceuticals. Phase III will focus on commercialization of identified glycosidases at the industrial scale for use in industrial synthetic pipelines. PROPOSED COMMERCIAL APPLICATION: ThermoGen proposes to isolate and characterize a large set of thermostable glycosidases for use by the synthetic community for the development of new pharmaceutical compounds. These enzymes may also be used to streamline the synthesis of existing commercial processes.